Investigating the roles of nuclear RNA modifications in gene regulation

RNA modification serves as a major posttranscriptional mechanism to regulate gene expression. Recent
advances in high-throughput sequencing have exponentially expanded the breadth and depth of RNA
modification types, substrate varieties and biological significance in normal developmental processes and the
genesis/progression of human diseases, including cancers, virus infections, and many neurodegenerative
diseases. In eukaryotic cells, all nascent mRNAs are born with a 5' triphosphate group (ppp) and then
immediately modified with an m7G cap in the nucleus. tRNAs and rRNAs also initially bear a 5' ppp group but
lose it during maturation via RNA cleavage events. Eukaryotic cells stringently regulate the 5' ppp group to
generate a cytoplasm free of ppp-RNAs, allowing them to easily detect viral RNAs, some of which bear a 5'
ppp group. Whether the ppp group is subject to alternative modifications to alter RNA fates remains to be a
knowledge gap in the RNA field. Recent studies by the PI and others have demonstrated that RNA
polyphosphatases, which remove two phosphates from the 5' ppp group, play important roles in regulating
nuclear small RNAs and viruses. The PI is also studying another modification on the ppp group, the m2,2,7G cap
on ncRNAs including U1 and U2 snRNAs. The PI found that influenza A virus (IAV) prefers to snatch the caps
of ncRNAs and utilize them to generate viral RNAs with these caps in canonical and non-canonical cap-
snatching processes, the latter of which was discovered by the PI recently. The PI is studying a third nuclear
RNA modification, the m5C on piRNAs, a relatively unexplored but important research area, since piRNAs
usually serve as the sensors in innate immune responses. In all, the PI proposes to investigate these three
types of nuclear RNA modifications. Unlike the PI's previous study focusing on small RNA pathways, this
proposal primarily focuses on how proteins in this RNA polyphosphatase family, especially PIR-2, regulate
mRNA and lincRNA, as the PI discovered that these proteins play non-small RNA mediated essential roles in
C. elegans. The PI will identify the substrates and systematically examine if and how this polyphosphatase
family regulates DNA replication, RNA transcription and chromatin modification in a variety of cells including
germline cells and neurons. This study will discover a new mode of gene regulation, which utilizes nuclear
RNA polyphosphatases to alter nascent ppp-RNA fate. The PI will also study how m5C on piRNA modulates
RNA stability and functions in target binding and processing, as m5C on other RNAs. Moreover, the PI will
examine if IAV preferentially utilizes the m7G caps derived from nascent U1 and U2 snRNAs or the m2,2,7G
caps derived from mature U1 and U2 in the nucleus, and if RNA splicing mediated by U1/U2 snRNA is
compromised by IAV. The proposed research is original and innovative, and bears direct relevance with human
health and disease. Not only will this study generate new gene regulation tools for research and disease
treatment, but it also promotes next generation researchers, especially those underrepresented /underserved.

Public health relevance
Project Narrative The 5' phosphate of nascent cellular and viral RNAs is stringently regulated to modulate gene expression and virus infection. How these RNAs are regulated by mechanisms other than capping reactions remains as a key knowledge gap. The PI will examine the roles and mechanisms of a novel and conserved RNA polyphosphatase family in regulating cellular mRNAs and lincRNAs, and the roles of two other modifications in regulating piRNAs and viral RNAs, likely generating new gene regulation tools for biomedical research and disease treatments.